Studying the function of human genetic variation in the light of 3D genome organization

Abstract
The search for causal genetic variants associated with specific diseases among many variants identified by
genome-wide association studies (GWAS) has been rejuvenated several times by the increase in throughput,
resolution and the number/modality of experimental techniques that are broadly available. Advances in capturing
cell-type-specific physical proximity among genomic regions also added a new dimension for this search by
revealing the importance of 3D genome organization in interpreting the role of genetic variants in gene regulation.
A number of combinations of these different techniques have proven useful in identifying a number of causal
variants but many major challenges remain in our goal towards creating complete maps of genotype-phenotype
associations for complex diseases. Our recent focus has been to address an important gap in the current
knowledge of how genetic variants may impact 3D genome organization with or without a measurable impact on
gene expression of the cell state/type that is available for molecular characterization. We have identified a
number of genetic variants that associate with read coverage, strengths of specific loops and/or overall
connectivity of large genomic regions. Leveraging our expertise in computational analysis and the newly
established experimental component of our lab, we will address a number of questions emerging from our recent
findings within the next five years. We will first define and characterize the role of genetic variants, which we
found to be associated with specific chromatin loops and/or overall connectivity of regions harboring regulatory
elements in specific human immune cell types. Next, we will perform long read-based assays and develop
accompanying analysis methods to resolve allele-specificity and connection modality of multi-way interactions
involving regulatory elements. Throughout the project period, we will continue developing computational methods
for integrative, comparative and high-resolution analysis of conformation capture data. As we have done before,
our methods development will be in alignment with biological questions we are trying to answer but with flexibility
and generalizability in mind for their broad utility by other researchers.

Public health relevance
Narrative We need to understand how differences in our genomes, coupled with environmental factors, translate into changes in specific biological processes to explain the vastly different outcomes among individuals when faced with an infection or in terms of their disease risk for having autoimmune conditions or cancer. However, human genome is complex even when studied as a linear DNA sequence and its three-dimensional folding, which itself is impacted by differences in this sequence, adds another layer of complexity to interpreting how cells utilize over a million different control switches to orchestrate a specific gene expression program that is precise yet flexible. This project uses human immune cells to study how differences in genome sequence lead to changes in genome function, and in turn disease risk and outcome, through calibrating genome’s three-dimensional organization.